TOLERANCE AND PHARMACOKINETICS OF SERTRALINE IN CHILDREN AND ADOLESCENTS

This pharmacokinetic study is being done to determine the safety, tolerability, and efficacy of sertraline after single and multiple dose administration in children and adolescents with obsessive/compulsive disorder or depression. This research will generate dose-blood level curves and pharmacokinetic coefficients for sertraline when administered to children and adolescents. Elimination rates and half-life data will be calculated, as well as hormone levels in patients.